Polyamine Transport in Schistosomes

Summary:
Schistosomes are intravascular parasitic worms that cause the debilitating disease schistosomiasis which
affects > 200 million people in > 70 countries. In this proposal, we focus on polyamine metabolism in
schistosomes. Polyamines are ubiquitous organic compounds that play multiple vital roles in cellular
physiology. An exhaustive search of genome databases reveals that schistosomes lack all the de novo
polyamine biosynthetic enzymes. This makes schistosomes the only known metazoans that are auxotrophic
for polyamines. How these worms acquire these essential metabolites is not known. The P5-type ATPase,
CATP5, identified in the nematode C. elegans has been shown to function as a polyamine transporter. Here
we describe our newly identified CATP5 homolog in S. mansoni - SmCATP5 - that is found in the schistosome
tegument (skin) where, we hypothesize, it functions to import polyamines from host blood. Knockdown of
SmCATP5 expression using RNAi debilitates the worms in culture, while polyamine supplementation enhances
worm viability. In this proposal, we aim to characterize the functionality, specificity and kinetics of polyamine
transport in schistosomes. We will examine SmCATP5 function using a heterologous expression system in a
polyamine-uptake-deficient cell line (CHO-MG) as well as directly in schistosome parasites. This work is
designed to reveal the physiological function of SmCATP5 and should yield significant new information on the
molecular mechanisms used by schistosomes to obtain vital nutrients (polyamines). Since schistosomes are
completely dependent on their hosts as a source of polyamines, blocking SmCATP5 function should debilitate
the worms and could form the basis of a new anti-schistosome therapy – the long-term aim of this work.

Public health relevance
Project Narrative Schistosomes are parasitic worms that infect the bloodstreams of over 200 million people globally causing the serious disease schistosomiasis. In this work we aim to understand how the worms obtain essential nutrients (polyamines) necessary for their survival and growth. We aim to target these capabilities to debilitate the worms and cure infection.